Core A: Protein Sciences

PROJECT SUMMARY – CORE A: PROTEIN SCIENCES
Core A (Protein Sciences) will provide essential support to our Projects and Cores in three areas: protein
production and characterization, high-resolution structure determination, and process development and
technology transfer. Core A’s protein production and characterization efforts, led by Dr. Neil King and Lauren
Carter, will leverage the extensive facilities and equipment at UW’s Institute for Protein Design (IPD) as well as
its unique expertise in nanoparticle immunogens. Rigorous characterization and quality control testing will ensure
the provision of high-quality antigens, nanoparticle immunogens, and protein-based reagents to support the
scientific efforts of Projects 1 (Veesler), 2 (King), and 3 (Pulendran). Structure determination by both X-ray
crystallography and cryo-electron microscopy will be led by Dr. David Veesler and will make use of state-of-the-
art, in-house facilities including UW’s Arnold and Mabel Beckman Cryo-EM Center. High-resolution structures of
designed antigens, nanoparticle immunogens, and antigen-antibody complexes will provide critical information
to guide the iterative design of stabilized antigens and broadly protective vaccines in Project 2. Process
development and technology transfer of our lead vaccine candidates (a pan-sarbecovirus vaccine at the end of
Year 2 and a pan-betacoronavirus vaccine at the end of Year 5), led by Dr. Neil King and Lauren Carter, will
build upon the IPD’s proven track record in translating innovative protein-based medicines and vaccines to
industry partners. A dedicated team at the IPD will develop the methods and documentation for a comprehensive
technology transfer package that will speed preclinical and clinical development of our broadly protective
coronavirus vaccines.